Neural Mechanisms and Recovery of Language Production Deficits in Aphasia

Aphasia is a common outcome following brain injury and often leads to long-term disability and
diminished quality of life. Language production disorders in particular, such as difficulty finding the right word
or problems speaking in sentences, are the most common symptoms of aphasia, and significantly hinder
communication and social participation. While some people with language production deficits recover well
during the first year after injury, others will not, and this discrepancy in outcomes is largely unpredictable. Many
factors affect recovery patterns across individuals, one of which is the involvement of different neuroanatomical
structures in the resulting impairment and subsequent degree of recovery. Surprisingly, little is known about
structural changes in the brain accompanying recovery from language production deficits in aphasia, though
preliminary evidence suggests they may be better predictors of recovery than traditionally-used functional
change measures.
The proposed longitudinal, multimodal neuroimaging study will explore the patterns of recovery in a
large group of individuals with aphasia following stroke. By combining a number of novel techniques, we will
investigate the contributions of numerous gray and white matter structures to the recovery of language
production deficits. Fifty individuals with aphasia will be tested at 1-, 3- and 12-months post stroke on various
measures of language production at the word, sentence and discourse level to establish baseline measures of
performance and monitor changes across the different stages of recovery. At the same three time points,
participants will undergo structural MRI and high angular resolution diffusion imaging (HARDI) to determine
lesion site, white matter integrity, and changes in grey and white matter over time.
The first main objective of the study is to determine which damaged cortical regions and white matter
pathways impede recovery of language production throughout the first year. The second main objective is to
measure neuronal changes in gray matter morphometry and white matter integrity that accompany observed
behavioral improvement. Evaluating different time periods during the first year post-stroke will enable us to
tease out neural indices predicting, impeding, and supporting language recovery at different stages.
The proposed project will be the first comprehensive longitudinal study using state-of-the art techniques
to examine plasticity within gray matter regions and white matter tracts and their contribution to recovery of
different language levels over the course of one full year. In the end, the results of this study will provide
important insights into factors contributing to successful recovery of language abilities and enable clinicians to
utilize neuroimaging information in prognosis and selection of the most optimal treatments.

Public health relevance
Each year roughly 80,000 Americans develop aphasia, or language disorder, as a result of stroke, head injury or other neurologic insults. Most individuals with aphasia have difficulty producing words and sentences which impairs their ability to communicate naturally. Some have an even more severe disorder that prevents them from producing any words at all. Some people recover very well from this disorder, while others do not, and the reason why is unclear. The proposed study will use state-of-the-art brain imaging tools to examine the underlying brain structures important for recovery of language production. We will also focus on the fiber pathways that connect these brain regions to one another, as we have found them to be critical for supporting speech and language functions and expect them to play a key role in recovery, as well. Information resulting from this study will provide clinicians with the information they need to give people with aphasia the most accurate diagnosis, prognosis, and effective treatment to date.